TREATMENT OF MULTIPLE SCLEROSIS BY ORAL MYELIN ANTIGEN

Double-blind, placebo-controlled one year study of efficacy/safety or oral administration of bovine myelin to relapsing-remitting M.S. patients, in reducing frequency of M.S. attacks.